Glycosaminoglycan-enabled technologies to reprogram chronic inflammatory states

PROJECT SUMMARY
The severity of traumatic injuries has increased in recent years, resulting in further complications that can impair
patient recovery or even result in death. The rate of injuries that become chronic wounds has also increased in
recent years. In both the acute and chronic injury site, there are key regulators of inflammation needed to protect
the body from pathogens, remove damaged tissue, and recruit new vessels to supply nutrients to tissues
undergoing repair. Failure to balance these beneficial hallmarks of inflammation with a transition to tissue
regeneration has resulted in secondary tissue damage and chronic injury progression. Immune cells, such as
macrophages, remodel the extracellular matrix and release cytokines to govern the injury microenvironment, but
dysregulation of these processes can result in chronic inflammation and non-healing wound formation. Locally
occurring or exogenously delivered chondroitin sulfate (CS) is a potent regulator of inflammatory cytokine
signaling and can help restore balance in dysregulated inflammatory conditions. Moreover, CS can directly
modulate immune cells towards anti-inflammatory phenotypes. However, uncontrolled CS delivery can impede
tissue repair by creating a physical barrier to local cells. Establishing a balance between modulating inflammation
and promoting repair with CS will require investigation of the specific role of CS-presentation on the local immune
response. To that end, the goal of this project is to engineer CS biomaterials that control CS presentation in the
injured tissue and reprogram inflammatory immune states to support resolution of chronic inflammation and
promotion of tissue repair. Over the next 5 years, we will investigate the use of nanoscale and microscale CS
biomaterials to resolve excess inflammatory cytokine activity and reprogram immune phenotypes towards an
anti-inflammatory, pro-regenerative state. These materials will be evaluated through in vitro studies to identify
intrinsic and extrinsic molecular mechanisms by which CS-presentation reprograms immune cells. Translational
mouse mouses will be used to investigate CS-presentation in tissue localized inflammation as an acute strategy
to modulate chronic disease progression as a prophylactic strategy, and as a chronic strategy to treat chronic
inflammation. Two distinct injury models that experience chronic inflammation through immune dysregulation will
be utilized. The first model that will be employed is a rodent model of spinal cord injury, as there is no cure for
paralysis associated with the injury, in part due to the robust inflammation that results in secondary injury and
progresses into a chronic diseased state. The second model used will be a rodent skin injury model, as the acute
injury can be used to test therapeutic outcomes that can subsequently be evaluated in chronic, non-healing skin
wounds. Development of strategies for chronic, non-healing wounds is essential as there is no unifying treatment
strategy, and of the therapies that exist, tissue repair is inconsistent across patients. Use of two disparate injury
models will lead to an improved understanding of the role of CS on the local immune cells responsible for healing
and will enable CS therapies that can re-establish immune balance without impairing tissue repair.

Public health relevance
Project Narrative The severity of traumatic injuries, as well as complications arising during wound healing, are on the rise, resulting in increased disability and mortality in the US population. The goal of this project is to study the acute imbalance in inflammation that leads to disease progression, and apply this knowledge to engineer nano- and micro-scale biomaterial strategies to resolve chronic inflammation in traumatic and non-healing wounds. These studies will lead to the development of bio-inspired material that can remediate intrinsic and extrinsic inflammatory pathways, resulting in a unifying traumatic injury and wound care strategy for improved patient outcomes.